Mitonuclear Communication During the Pathogenesis of Inflammatory Bowel Disease

Project Summary/Abstract:
There is increasing appreciation for mitochondrial dysfunction as both a cause of and therapeutic target for
inflammatory bowel disease (IBD). The broad goal of this proposal is to determine how abnormal mitochondrial
dynamics and function within the intestinal epithelium contribute to IBD pathogenesis and whether reversing or
preventing dysfunction can improve clinical outcomes. Mitochondrial homeostasis is maintained via
mitochondrial biogenesis and the coordinated process of mitochondrial dynamics, including fusion, fission and
mitophagy, working in concert to balance energy metabolism and regulate mitochondrial structure and function.
We previously demonstrated that downregulation of PGC1α in the intestinal epithelium of patients with ulcerative
colitis (UC) results in a decrease in biogenesis, contributing to a decline in mitochondrial function and the
antioxidant response. We and others went on to describe a “mitochondriopathy” of UC, representing the
most significant transcriptomic hallmark of treatment-naïve pediatric-onset UC. Despite these findings,
several key questions remain. First, the hallmark of this mitochondriopathy is a transcriptional downregulation of
PGC1, yet the cause of this downregulation remains unknown. We now provide evidence of Parkin-interacting
substrate (PARIS)-mediated PGC1α transcriptional inhibition during disease, secondary to a decrease in cellular
PARKIN. Second, apart from a decrease in mitochondrial biogenesis, it is not known how PGC1 downregulation
directly impacts mitochondrial dynamics. Finally, it is unclear how PGC1-dependent metabolic reprogramming
of the intestinal epithelium may impact mucosal healing and the ultimate outcomes of IBD. Our working
hypothesis is that the mitochondriopathy of IBD is a signature feature of disease, with important functional
consequences, and one that is amenable to therapeutic targeting. In Aim 1, we propose to investigate the
PARKIN-PARIS-PGC1α axis using multiple, inducible transgenic mouse strains in models of intestinal injury and
repair. In Aim 2, we evaluate the impact of PGC1α downregulation on mitochondrial dynamics during IBD utilizing
novel approaches to live-cell imaging of intestinal organoids. Finally, in Aim 3 we will evaluate the impact of
PGC1α-driven metabolic flux on pro-inflammatory and pro-fibrotic pathways in UC using human intestinal
organoids (HIOs) induced from pluripotent stem cells (iPSCs), potentially outlining a novel mechanism for an
understudied and devastating complication of chronic disease. Targeting the epithelial mitochondriopathy of IBD
could offer the opportunity to minimize the epithelial impact of disease, improving mucosal healing while still
mitigating the robust immune response in patients with immune-mediated therapeutics.

Public health relevance
Project Narrative: This project is designed to investigate the role of mitochondrial dysfunction in the intestinal epithelium of patients with inflammatory bowel disease (IBD), with a focus on how impaired mitochondrial dynamics and subsequent changes in cellular metabolism contribute to IBD pathogenesis. Building on our previous work demonstrating a mitochondriopathy in pediatric-onset ulcerative colitis (UC), we aim to clarify a novel mechanism for the transcriptional downregulation of PGC1α and outline how this downregulation impacts mitochondrial dynamics, metabolism, and tissue repair. Our findings could reveal novel therapeutic targets to restore mitochondrial function, improve mucosal healing, and mitigate fibrosis in IBD.